INDUCTIVELY POWERED MICROSTIMULATOR

The objective of this contract is to develop and enhance the reliability of implantable, microsized receiver-stimulators (microstimulators) that are powered and controlled by inductive coupling from an extracorporeal transmitter and coil.